Effects of Neighborhood Environment on Child Behavioral Health

ABSTRACT. Healthy child development is essential to long-term wellness because it enables human capacity
to participate in economic, social, and civic life; however, not all children experience healthy development. Many
children are affected by social determinants of health (SDOH) including structural inequities resulting from their
neighborhood environment. Neighborhood environment, a powerful SDOH, profoundly shapes children's
physical, mental, and emotional health, and influences opportunities for children to achieve long-term health.
Parents who reside in poorer neighborhoods also tend to experience ineffective coping, parenting challenges,
and suboptimal family cohesion, which may influence behavioral dysregulation and academic performance in
early childhood. Behavioral dysregulation – an impairment in ability to self-regulate behaviors characterized by
reflexive, automatic, and emotional reaction of acting out – is associated with the development of common
childhood psychopathologies. In addition, behavioral dysregulation is associated with poor academic
performance, another important indicator of long-term child health. Studying these outcomes in early childhood
provides windows of opportunity to find solutions to promote life-long health and close the gap on health
disparities later in life. Parenting behavior and family cohesion (positive relationships between family members
and the level of closeness, emotional bonding, and support) are modifiable indicators of family relationships that
can be targeted to mitigate the effect of neighborhood environment on child behavioral dysregulation. In this
NRSA F31 proposal, using rich publicly available data from the Environmental Influences on Child Health
Outcomes (ECHO) Program, I will adopt the Creating Nurturing Environments framework to address the following
specific aims: 1) Identify the effect of neighborhood environment on behavioral dysregulation and academic
performance in early childhood (1-6 years); 2) Determine the degree to which family relationships mediate the
effect of neighborhood environment on behavioral dysregulation and academic performance. The accompanying
career development plan will build the foundation for me to a) Build expertise in child development with
emphasis on behavioral health and academic performance; b) Build expertise in neighborhood environment and
its effect on child health; c) Advance skills in quantitative research methods for data analysis such as structural
equation modeling; d) Gain experience in team science skills and accomplish professional development goals.
I have a strong mentorship team who are influential in their respective fields with robust NIH-funding and
publications, dedicated to my growth and development throughout this F31 award and my career. The career
development and research plan will guide me to achieve my ultimate career goal of becoming an independent
nurse scientist who advances the science in addressing SDOH and promoting child health. This proposal aligns
with the new NINR Strategic Plan with its focus to understand SDOH to promote health equity in neighborhoods
with shared characteristics of strengths and vulnerabilities.

Public health relevance
PROJECT NARRATIVE Neighborhood environment, a powerful social determinant of health, has a profound effect in shaping children’s physical, mental, and emotional health and in influencing opportunities for children to achieve long-term health. This project will explore the effect of neighborhood environment on child behavioral dysregulation and academic performance, and determine the degree to which family relationships, a modifiable factor, mediates the effect of neighborhood environment on behavioral dysregulation and academic performance in early childhood. This award will support my development toward becoming an independent nurse scientist dedicated to advancing the science in addressing social determinants of health and its effects on long-term child health and wellness.